HUMAN MEGAKARYOPOIESIS

Using a radioimmunoassay specific for in vitro human megakaryopoiesis developed here in 1985, this study is designed to elucidate the physiologic control of platelet production and characterize defects in thrombocytopenic and thrombocytotic patients.